Testing of the VTA - EC Ca2+ – BBB Hypothesis

Abstract
In complex natural environments, optimal behavior requires a precise understanding of body state. However,
information transmission between body and brain is limited by the blood-brain barrier (BBB). Chiefly comprised
of tightly coupled Endothelial Cells (ECs), this barrier is canonically considered a static blockade to most
molecules during health. Preliminary Data from our lab shows that, in contrast to this canonical view, the BBB
can be highly dynamic, with rapid, local moments of increased permeability. These ‘Plume Events’ can be driven
by behavioral events and optogenetic activation of Ventral Tegmental Area (VTA) Axons. The circuit mechanisms
underlying these newly-discovered Plume Events are unknown. Rapid EC Calcium Events (ECCE) are a
strong candidate driver, as increased EC Calcium (Ca2+) enhances BBB permeability ex vivo, and recent
studies show rapid, discrete EC Ca2+ events in anesthetized mouse Neocortex. My Preliminary Data support
this Hypothesis: Optogenetic drive of VTA Axons evokes ECCE in Neocortical vessels within 1-2s. I have also
found that chemogenetically driving Chloride (Cl-) channels, known to increase EC Ca2+, can ‘open’ the BBB.
Here, I systematically test three closely-related Hypotheses. In Aim I, I test the prediction that VTA Axon
activity, endogenous and optogenetically-driven, evoke ECCE; In Aim II, I test the prediction that ECCE predict
Plume Events; and, in Aim III, I test the prediction that externally activating EC Cl- channels can drive both BBB
permeability and ECCE. I will employ 2-Photon imaging in awake mice under multiple behavioral contexts, and
cellular control tools co-developed in our lab. All studies will be conducted in the Primary Somatosensory ‘Barrel’
Neocortex (SI), a key neurovascular and behavioral model system. Even if my predictions are not supported,
these data should provide unique insights and may have clinical relevance (e.g., to targeted opening of the BBB).
My mentor Dr. Christopher Moore has extensive experience with all of these methods. Further, Dr. Moore’s track
record of expertise in exactly my desired research domain, and history of excellent mentorship results, make me
confident that I am well-positioned to thrive during graduate work. My co-Mentor Dr. Diane Lipscombe is an ideal
complement, as she is a leading expert in Ca2+ channel structure and function, and in linking these variables to
behavior. Their collective expertise, coupled with the Brown Neuroscience Department’s classes, technical and
pedagogical resources, and supportive culture, will ensure I have the mentorship and support necessary to
thrive. I will broaden my graduate learning experience through taking high-level classes, attending frequent talks
from a wide range of leading neuroscience researchers, and engaging with a robust peer network. Most
importantly, performing my Specific Aims within this training environment will provide ideal training for
reaching my long-term research goals.

Public health relevance
PROJECT NARRATIVE Increasingly, the Blood-Brain Barrier is viewed as a dynamic regulator of pharmacological signaling between brain and body. Chiefly comprised of tightly coupled Endothelial Cells (EC), the Blood-Brain Barrier’s permeability is modulated by EC calcium signaling processes across timescales. Here, I systematically test the hypothesis that behavioral salience and reward signaling evokes fast, local EC Ca2+ dynamics to modulate BBB permeability in Somatosensory Neocortex on short timescales.